Center for Innovative NeuroTech Advancement (CINTA) - Administrative Core

Abstract: ADMINISTRATIVE CORE
The Administrative Core is the central element of the proposed hub and responsible for leadership, management, and oversight of the other Cores with input from the Steering Committee. CIMIT has extensive experience in setting up Administrative Cores in its previous work as the Point-of-Care Technology Research Center in Primary Care, as the Coordinating Center for POCTRN, and as the primary architect for the administrative structure for RADx Tech. The Administrative Core will provide governance, set policy, and continuously improve the efficiency of CINTA based on feedback from the Steering Committee, real time metrics, and achievement of benchmarks. The Steering Committee will be part of the Administrative Core and charged with providing CINTA leadership with strategic oversight and recommendations for accelerating commercial translation and clinical impact. The CINTA Coordination Team within the Administrative Core, composed of the PI, Co-PI, and Core leads, will work closely with the Steering Committee to make all major decisions. Dr. Schachter has drawn on his career-long interests in neurology, technology, and patient advocacy to receive commitments from national leaders to join the Steering Committee, who reflect a wide range of expertise corresponding to areas of interest of the NIH Participating Organizations, as well as relevant life experiences and work with patient communities. To create a patient-centered focus for CINTA, the Administrative Core will create a Consumer Advisory Board within the Administrative Core to convey the voice of the patient to CINTA. The Administrative Core will work with the Outreach Core to develop and implement clinical needs assessments in advance of each solicitation to identify unmet needs in nervous system disorders where technology-based solutions would have the highest impact. Utilizing the information gleaned from the needs assessments. The Administrative Core will then create, post, and disseminate a solicitation. CINTA will leverage CIMIT’s extensive experience with solicitations and subproject support to identify the most promising technologies and provide milestone-driven funding, resources, and relevant expertise to assist innovators in rapidly moving technologies to human-grade prototypes. To support these processes and roles, CIMIT created and has continuously improved and utilized, a secure, web-based infrastructure to enable efficient and effective operations. This infrastructure consists of: 1) the CoLab platform, which is used to manage solicitations, and specifically the flow of applications through the multi-stage, interactive project selection process, and 2) the GAITS platform, which helps project teams successfully navigate and accelerate the challenging journey of innovation in healthcare. CINTA will follow all applicable NIH guidelines and will abide by NIH standards for confidentiality, conflict of interest, and data security. CINTA is committed to embedding the advice of the Steering Committee membership, the CINTA Coordination Team, as well as the voice of the patient, into the work of the Administrative Core.